Increasing Diversity in and Equitable Access to Applied Learning in Disaster Research Response: IDEAAL DR2

Project Summary
The deleterious health impacts of disasters exacerbate pre-existing vulnerabilities and inequities,1 and
disproportionately affect racial and ethnic minorities and the poor.2,3 However, the evidence base guiding our
nation’s preparedness and response has been described as “seriously deficient.”4 Research conducted in the
aftermath of a disaster is essential to building this evidence base, but is inherently challenging.5–7 Accordingly,
an established and trained disaster research workforce is essential.4 However, we are unaware of any training
that provides researchers hands-on, experiential training in environmental and public health disaster research
methods, nor any with a specific focus on supporting underrepresented minority scholars in this domain. In
response, the Increasing Diversity in and Equitable Access to Applied Learning in Disaster Research
Response: IDEAAL DR2 program will provide intensive skills-based training in environmental and public
health disaster research. We will partner with the Bill Anderson Fund (BAF), the only nonprofit organization
that focuses explicitly on supporting underrepresented minority (URM) scholars in hazards and disaster
research, to design an inclusive recruitment process and training program. IDEAAL DR2 will train up to 100
early career researchers across the U.S., with an intentional focus on URM scholars, to 1) Increase the
knowledge and awareness of environmental and public health disaster research methods and skills among
interdisciplinary, early career researchers who are interested in conducting public health-focused hazards and
disaster research; and 2) Increase diversity, equity, and inclusion in hazards and disaster research by
providing access to the necessary training, equipment, technology, and advising to support early-career
researchers from historically underrepresented backgrounds in the development and completion of their own
research projects. The course will include five modules with pre-course, in-person, and post-course
components: 1) foundations of disaster research; 2) community engagement in disaster research, 3) disaster
research methods; 4) tools and instrumentation for disaster research; and 5) disaster research design and
implementation. For 12 months following the in-person course, Fellows will design and implement an
independent disaster research project, leading to a paper of publishable quality, supported by monthly training
workshops and peer accountability groups. To circumvent economic and institutional barriers that perpetuate
systemic inequities, five URM Fellows annually, recruited in partnership with the BAF, will receive dedicated
research advising and financial support for their project. Interdisciplinary program faculty have a strong and
long-standing history of collaboration. They will be guided by an advisory committee and results from a
rigorous formative and summative evaluation program. Course and evaluation materials will be disseminated
broadly through the NIEHS DR2 and NIEHS Partnerships for Environmental Public Health Resources Portal,
and evaluation findings will be shared with NIEHS and through conference presentations and publications.

Public health relevance
Project Narrative Climate change is increasing the disproportionate environmental and public health impacts of disasters on marginalized communities, demanding action to address existing gaps in environmental and public health disaster research training in graduate and continuing education, and to create pathways to increase representation of trained underrepresented minority (URM) scholars. In response, the University of Washington will develop a short course, Increasing Diversity in and Equitable Access to Applied Learning in Disaster Research Response: IDEAAL DR2, led by faculty with expertise and experience conducting interdisciplinary health-related disaster research to provide such training to up to 100 scholars. We will partner with the William Averette Anderson Fund (BAF), the premiere non-profit organization dedicated to diversifying the fields of disaster and hazard research and practice, to create an inclusive recruitment strategy and provide targeted advising and financial support to URM scholars and advisors.